Yale Clinical and Translational Science Award

Contact PD/PI: Smith, Brian Richard 1. Overall: Project Summary The Yale Center for Clinical Investigation (YCCI) was created in 2005 to advance Yale's clinical research mission. One year later, YCCI became the home of the Yale CTSA. At YCCIs inception, Yale was a national leader in T0-T2 translational research, basic/translational science training, and it supported distinctive fellowship programs such as the Robert Wood Johnson Clinical Scholars Program. Since then, the CTSA has had a transformative impact linking diverse components of the Yale community in T1-T4 research, providing the central infrastructure for the effective conduct of ethical, innovative, rigorous, and reproducible research, and in training the next generation of research leaders. By any metric of scale, breadth, quality, and impact, both the CTSA's research enterprise and its educational mission have been enormously successful for Yale. This renewal application does not simply seek to maintain excellence, but to enable YCCI to drive the continued transformation of the Yale T1-T4 translational research mission and its predoctoral and postdoctoral training mission and to promote collaboration across CTSA hubs. First, it will support informatics and computational advances that drive the emergence of a learning health system. In so doing, it will draw on the Yale New Haven Health System, a six-hospital 2,681-bed consortium that provides more than 2.4 million outpatient visits from patients from upper Westchester county, throughout Connecticut, and southern Rhode Island. It will also prepare young scientists to draw on this infrastructure to conduct research that influences the future of healthcare. Second, it will support technological and scientific advances in areas that will support the emergence of personalized healthcare, including multi-omics and imaging. YCCI will provide pilot grant support and training to foster the development of research careers and research teams that can deepen our insights into pathophysiology and build toward personalized treatments. Third, it will engage a broader and more diverse group of faculty, trainees, and community representatives to collaborate in the mission of addressing healthcare disparities that constitute a major burden on patients, their families, and on public health. To support this mission, YCCI will also foster the development of careers in community-based research from a diverse group of young investigators and enhance the overall clinical research workforce. Project Summary/Abstract Page 177 Contact PD/PI: Smith, Brian Richard # ! ! % # # ! #! !# ! & # # ! $ ! ! ! # ) # # % ! $ # # # #! # ! ! # ! # #! # % ! # ! ' % ! #(* $## # $ # # % ! # & # # #! # & % # (# # ! # ! # (# # # ! # $ # & & ! & # # ! # # ! # $!# ! ! &# $ # !( # % % # % ! # % ! # #! # ! ! % # # # ! $# # # # ! & ! ! $ # ! # # $ # # ! # (#

Public health relevance
Project Narrative Page 178